Effects of Dietary Phosphorus Bioaccessibility and Calcitriol onPhosphorus and Calcium Whole-Body Balance and Kinetics in Moderate CKD

PROJECT SUMMARY/ABSTRACT
Chronic kidney disease (CKD) is highly prevalent, affecting approximately 37 million U.S. adults. CKD-
mineral and bone disorder (CKD-MBD) is a common comorbidity of CKD that results in increased risk of
cardiovascular and bone disease and associated morbidity and mortality. Abnormal phosphorus (P) metabolism
is central to the development of CKD-MBD and is intimately linked with calcium (Ca) metabolism. Incomplete
understanding of the underlying physiology of Ca and P in CKD and in response to treatments is a major
knowledge gap that hinders research and clinical progress in CKD-MBD. P and Ca physiology is complex and
involves interacting effects of three regulatory hormones, calcitriol, parathyroid hormone, and fibroblast growth
factor-23, on a multi-tissue axis of intestine, kidney, and bone. Despite the complexity, most human research
has relied on serum and urine Ca and P measures to infer aspects of whole-body physiology. Yet, prior work
has shown that serum and urine Ca and P are not reliable markers of whole-body balance or intestinal absorption
in CKD. Formal metabolic balance studies combined with isotope tracers can reveal the underlying whole-body
Ca and P physiology and, notably, can distinguish intestinal absorption from bone resorption and formation. This
project seeks to fill this knowledge gap through two specific aims. Aim 1 will determine the effects of dietary P
restriction on P and Ca intestinal absorption, whole-body balance, and kinetics in adults with moderate CKD.
Aim 2 will determine the effects of calcitriol, a key P and Ca regulatory hormone, on P and Ca intestinal
absorption, whole-body balance, and kinetics in adults with moderate CKD. Each aim will be addressed in a
clinical study using a two-phase randomized cross-over design with controlled feeding and metabolic balance
and kinetics methods in adults with moderate-stage CKD. In Study 1 (Aim 1), subjects will be randomly assigned
to a cross-over order of low and high diet P, achieved through manipulation of P source based on current
understanding that inorganic P sources have much higher bioaccessibility compared with P found naturally in
plant and animal foods, as recommended by current guidelines. In the second study (Aim 2), subjects will be
randomly assigned to a cross-over order of calcitriol and identical placebo. Each study will consist of a 1-week
run-in period on the controlled diet/intervention, 1-week full metabolic balance period with complete urine and
stool collections and oral and intravenous administration of P and Ca isotopes for kinetic modeling to determine
components of P and Ca metabolism including: intestinal absorption, renal clearance, and movement to and
from bone, with kinetic measures continuing during a third week. After a washout period, subjects will cross-over
to the second intervention period. The long-term objective of this project is to advance foundational knowledge
of whole-body P and Ca physiology in CKD that will contribute to progress in translational and clinical research
with the goal of reducing morbidity and mortality associated with CKD-MBD. This relates to the mission of the
NIDDK to support research aimed at improving the health and quality of life of patients with kidney disease.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease (CKD) affects approximately 37 million (1 in 7) U.S. adults, many of whom experience mineral and bone disorders (CKD-MBD) that increases risk for cardiovascular events, bone fractures, and death. Dietary and pharmaceutical treatments for CKD-MBD have diverse effects on serum calcium and phosphorus levels, but their effects on the underlying physiological processes of calcium and phosphorus balance are largely unknown. This project aims to determine the effects of two common CKD-MBD interventions, dietary phosphorus restriction and calcitriol (active vitamin D), on whole-body calcium and phosphorus balance, intestinal absorption, renal excretion, and bone turnover in two human clinical trials, with the overall goal of advancing foundational knowledge of calcium and phosphorus physiology in CKD that will support progress towards preventing morbidity and mortality associated with CKD-MBD.